Composition and function of Optix-Cofactor transcription complexes in the eye.

Abstract
Drosophila Optix belongs to the evolutionarily conserved SIX family of homeobox transcription
factors. Family members control cell fate, morphology, proliferation and/or survival in multiple tissues
and organs of metazoans, including the eye. In Drosophila, Optix functions as a critical regulator of visual
system development. Optix homozygous mutant tissue shows defect in retina neurogenesis and
patterning of the ocelli. In addition, Optix is an essential regulator of neuroepithelial maintenance and
patterning in the Drosophila brain, specifically in the optic lobe. The vertebrate homologs SIX3 and SIX6
are also required for the development of the mammalian eye and brain, and SIX3/6 mutations in
humans are associated with severe eye and brain malformation. Optix, as other SIX family members,
functions as a transcriptional regulator together with a variety of protein cofactors (CoFs) that modify
Optix activity, resulting in changes in the activation or repression of target genes and reporters. Hence,
to understand Optix protein function in specific developmental contexts, we need to identify the
discrete Optix-CoF complexes at work, define their properties, and understand their specific roles. We
propose here to characterize Optix-CoF complexes in multiple ways (Aim 1), and then to generate Optix
protein variants that fail to engage in either one or few critical protein-protein interactions to
demonstrate the context-dependent requirement for the affected complex(es) in cell culture (Aim 2).
Lastly, we will develop tools for the dissection of the complexes’ biological roles in vivo (Aim 3). The
research proposed here will lay the groundwork for detailed studies of SIX-CoF transcription complexes
in vivo under physiological conditions and define their specific developmental roles by uncovering the
precise biological processes they control through their transcriptional activity and TC-specific
transcriptomes. This work aims to further our understanding of the intricate ways in which these
transcription factors control fly eye development, and in which their dysfunction may lead to human
disease and birth defects.

Public health relevance
Project Narrative Fly Optix and its homologs human SIX3 and SIX6 are evolutionarily conserved transcription factors that control cell fate, morphology, proliferation and survival in the eye, and in other tissues and organs of metazoans. In humans, mutations in SIX family transcription factors and some of their partner co-factors (CoFs) have been shown to cause birth defects (e.g., HPE2, Microphthalmia, and Coloboma) and susceptibility to disease (POAG). The strong conservation of SIX factors and CoFs from human to fly enables us to use the fly to perform detailed analyses of Optix-CoF interactions and gain insight not only into fly eye and brain development but also into properties of SIX-CoF complexes most likely relevant to human birth defects and disease.